Mechanisms of Hematopoietic Stem Cell Reprogramming by Type II Interferon

Project Summary
A hallmark of the hematopoietic system is the ability to respond to inflammatory challenges. Central to this
response are hematopoietic stem and progenitor cells (HSPCs), which balance self-renewal and differentiation
programs to maintain stable blood cell output. In response to acute inflammation, such as infection, pro-
inflammatory cytokines activate HSPCs to rapidly augment innate immune cell production. Although initially
critical for pathogen control, persistent and non-productive inflammation can drive HSPC dysregulation and stem
cell loss, a key contributor to bone marrow failure syndromes, acquired neutropenia, and hematologic
malignancies. Certain inflammatory stimuli, including the mycobacterium BCG, induce durable epigenetic and
transcriptional reprogramming in HSPCs which is transmitted across differentiation to mature innate immune
cells with enhanced effector function upon restimulation. These findings suggest HSPCs can act as a reservoir
of inflammatory memory with functional consequences in differentiated immune cells, yet the cytokine signals
and molecular programs that establish HSPC memory are poorly understood.
This proposal aims to dissect the mechanisms through which Type II Interferon (IFNG) signaling in response to
BCG establishes durable memory programs in HSPCs and their innate immune progeny cells. In Specific Aim
1, we will characterize the cellular targets of IFNG signaling within the bone marrow (BM) niche required for
HSPC reprogramming, then define the contribution CD4 T lymphocytes to this response. In Specific Aim 2, we
will apply single cell multi-omics and epigenomics approaches to identify the epigenetic mechanism by which
IFNG signaling establishes durable memory programs in HSPCs, then trace the inheritance of these programs
across differentiation to innate immune cells. This project is ideal for a physician-scientist in training, given its
blend of cellular immunology and high-throughput sequencing approaches to dissect the durable impact of
inflammation on the hematopoietic system, along with the potential to uncover novel therapeutic targets to
address stem cell dysfunction in hematologic disease and augment innate immunity. With the mentorship of my
sponsor, co-sponsor, collaborators, thesis committee, Tri-I MD-PhD program leadership, and the support of this
fellowship, I will be well prepared to pursue and achieve my goal of being a physician-scientist and independent
investigator.

Public health relevance
Project Narrative Hematopoietic stem cells respond to pro-inflammatory stimuli to rapidly augment innate immune cell production, but persistent inflammation can drive stem cell dysfunction which contributes to bone marrow failure syndromes, acquired neutropenia, and hematologic malignancies. Type II Interferon signaling in response to the mycobacterium BCG is required for durable epigenetic and transcriptional reprogramming in hematopoietic stem cells, which is conveyed across differentiation to alter the function of innate immune cells. By identifying the cellular mediators, molecular pathways, and epigenetic mechanisms through which BCG-driven Type II Interferon signaling reprograms hematopoietic stem cells, this project aims to uncover the durable impact of inflammation in rewiring hematopoiesis and immune status alterations.